Muscular Dystrophy Specialized Research Center

CORE C SUMMARY
The overall goal of Core C is to foster the growth and development of the next generation of
neurologists, neuromuscular pathologists, and basic and translational scientists in an
environment where basic scientists and clinicians interact regularly to advance knowledge about
muscular dystrophy. Specifically, each year Core C will support training activities for Medical
Student, Postdoctoral, Graduate Student, and Undergraduate Research Fellows. The
educational efforts of the Center are vital because there is an urgent need for basic scientists
and clinicians who can partner to develop, test and implement muscular dystrophy therapies. By
establishing the Medical Student Fellowship, we will foster interest in academic child neurology
(with a neuromuscular focus) and related specialties supporting neuromuscular disease
patients. This full-time fellowship will enable up to three medical students per year to participate
in a range of MDSRC activities including care of muscular dystrophy patients in clinic,
evaluation of patients participating in Project 2 under the supervision of Dr. Mathews,
interpretation of muscle biopsies with Dr. Steven Moore, and exposure to clinical trials. The
Postdoctoral Research Fellowship will train scientists in the basic research of muscular
dystrophy, by providing a PhD, MD, or MD/PhD graduates with an intensive research
experience in Dr. Campbell's laboratory. This experience will be complemented by observation
of patient care in a clinical setting, enhancing the fellow's understanding and appreciation of the
clinical side of translational research. The Undergraduate Research Fellowship is designed to
provide an intensive research experience in an MDSRC laboratory that will encourage students
to pursue careers in translational science. All trainees will participate in the monthly Wellstone
Neuromuscular Conference, where clinical fellows and faculty present interesting cases with
discussion of literature and scientific trainees join in discussion. Wellstone trainees from Iowa
and the broader MDSRC and neuromuscular disease communities will be invited to actively
participate in the Family and Patient Conference hosted by Core A by presenting their research
and interacting with patients and families. The Iowa MDSRC plans to host additional
conferences focused on pediatric muscular dystrophies and synergies to be gained from sharing
information across diseases. Through these activities, Core C will accelerate the education
mission of the MDSRC and provide a vibrant training environment for clinician scientists.